American Academy of Audiology's Academy Research Conference (ARC) 2023-2025

PROJECT SUMMARY / ABSTRACT
The American Academy of Audiology’s Academy Research Conference (ARC) 2023-2025 will be the 15th-17th
meetings of this annual translational research conference. ARC is designed for both clinicians and researchers to
take a “deep-dive” together into a clinically important research area. The SPECIFIC AIMS of this conference
series are to (1) bridge the gap between clinical practice and academic research, (2) promote interactions
between scientists and clinicians that foster collaboration and mentoring, (3) facilitate mentoring and support of
future clinicians and researchers, (4) support expansion and diversity in research, and (5) disseminate research
related to hearing and balance.
ARC has been highly successful and adaptive to recent limitations for in-person learning. During the
Covid-19 pandemic, ARC 2020 and ARC 2021 were offered virtually, with 281 and 230 participants attending,
respectively, all while maintaining access to high quality researchers. Due to the positive response to these
virtual meetings, ARC 2023-2025 will be offered as virtual-only events.
The fields of audiology and hearing science are advancing quickly. We propose this CONFERENCE PLAN
to address methods of managing the most common auditory conditions – hearing loss and tinnitus. Novel
therapeutic interventions are on the horizon and may provide additional management options for treating
sensorineural hearing loss (ARC 2023). Further, expanding criteria for implantable devices will offer various
options for those with less severe hearing loss, previously only managed with traditional hearing aids (ARC
2024). Tinnitus remains a considerable concern, especially for patients with hearing loss, and often requires a
multidisciplinary care team to appropriately manage (ARC 2025). Each of these conferences will provide
attendees with an expanded view of current management options as well as information on how to prepare for
future interventions.
The ARC conference series reflects the Academy’s commitment to promoting the accessibility and
participation of underrepresented individuals in cutting-edge science. ARC’s DIVERSITY PLAN incorporates (1)
focused direction on identifying diverse speakers, (2) required diversity, equity, inclusion, and belonging (DEIB)
learning objective for all presentations, (3) registration stipends for those identified as belonging to an
underrepresented group (NOT-OD-20-031), (4) mentorship opportunities, and (5) childcare stipends.

Public health relevance
PROJECT NARRATIVE The American Academy of Audiology’s Academy Research Conferences (ARC) are intended to bridge the gap between clinical practice and academic research by engaging audiologists, scientists, and students in translational presentations and discussions on clinically significant research topics. ARC 2023-2025 exemplifies ARC’s focus on providing access to cutting-edge research for those in clinical practice by addressing significant areas of patient care and management, including future therapeutic options, expanding use of implantable devices, and managing chronic tinnitus.